Core B - Computer Services, Instrumentation and Imaging Core

CORE B - COMPUTER SERVICES, INSTRUMENTATION AND IMAGING CORE SUMMARY/ABSTRACT Core B will provided centralized technical support for the computer, electronic and imaging services needed for collection and analysis of experimental data. The services are an essential part of the protocol design, animal maintenance, data acquisition and data analyses of Projects I, II, and III. The experiments proposed in the current application require chronic measurements of cardiovascular variables in rats and mice. By providing leadership and technical support to all members of the PPG, we are able to provide sophisticated data collection and imaging systems to investigators in a timely and fiscally efficient manner. Core B will provide systems analysis and computer simulation services to assist investigators in understanding the integrative aspects of the mechanisms that are elucidated by each of the projects. Core B provides a variety of shared imaging technologies to all investigators on the Program Project Grant, so that high quality measurements can be made at a lower cost. Core B facilities and services are available to all members of the Program Project Grant and continue to be critical for the success of all projects in the current proposal. Personnel in Core B are readily available to provide expert technical support as well as assistance with the operation of any equipment or instrumentation within the core. This Core will lead to increased productivity of the Program Project Grant.

Public health relevance
CORE B - COMPUTER SERVICES, INSTRUMENTATION AND IMAGING CORE NARRATIVE Obesity and its cardiovascular and metabolic consequences, including hypertension, are major health issues affecting a large fraction of the US population. This Program Project Grant will provide new information about the underlying mechanisms by which obesity contributes to increased blood pressure and metabolic disorders in experimental models that are highly relevant to common, and difficult to treat, forms of human hypertension caused by obesity, preeclampsia, and postmenopausal hyperandrogenemia. This Core will provide technical expertise, mathematical modeling, computer services and imaging that will allow us to understand the pathogenesis of these disorders and to accomplish our long-term goal of developing a comprehensive systems analysis of cardiovascular dynamics and their control.